Development of a novel exosome-based nano-scavenger for targeted Amyloid-beta removal

PROJECT SUMMARY
Development of a novel exosome-based nano-scavenger for targeted Amyloid-
beta removal
Objective: To develop a novel exosome-based nano-scavenger (EBNS) for the targeted removal
of amyloid-beta (Aβ) proteins, offering a transformative therapeutic strategy for Alzheimer’s
disease (AD) and other amyloid-related disorders.
Background: Alzheimer’s disease, the leading cause of dementia among the elderly, is
characterized by the buildup of toxic Aβ proteins in the brain. Current AD treatments focus on
symptom management and Aβ-neutralizing therapies using recombinant human antibodies.
However, in addition to their side-effects, these antibody therapies are costly, offer limited benefits
in early stages, and are ineffective in late stages due to their inability to clear existing plaques and
poor bioavailability.
Innovation: Exosomes, cell-derived nano-vesicles, are pivotal in cell-to-cell communication and
can transport various macromolecules, including proteins, enzymes, and nucleic acids. Their
intrinsic tissue-penetrating ability positions exosomes as a promising class of nanomedicines for
neurological targets. Compared to conventional nano-vesicles like liposomes, exosomes offer
superior stability, biocompatibility, bioavailability, disease targeting programmability, and high
protein loading capacity. However, a significant challenge remains in engineering exosomes to
load both disease-targeting antibodies and amyloid-ddegrading enzymes.
Research Plan: We propose to develop an EBNS for targeted amyloid removal with the following
three specific aims: (1) Genetic engineering: Develop genetic strategies to load Aβ-targeting
antibodis and Aβ-degrading enzymes onto exosomes via an exosome-specific anchoring scaffold
in human cells. Determine the molecular pathways for exosome targeting and cargo delivery using
advanced molecular imaging techniques. (2) Isolation and characterization: Establish
procedures for the isolation and purification of exosomes. Characterize the physical, biochemical,
and biological properties of the isolated exosomes and evaluate their ability to target and clear
Aβ amyloids. (3) Production and evaluation: Produce therapeutic quality of EBNS from selected
source cells such as mesenchymal stem cells and 293Tcells. Develop assays to exam the
targeting and degrading abilities of the scavenger exosomes. Evaluate their safety and efficacy
through molecular and cellular assays.
Expected Outcomes: The successful completion of this study is expected to create a novel
EBNS system capable of targeted degrading of Aβ plaques, providing a promising new treatment
for AD. Additionally, this EBNS has the potential to be adapted for the development of similar
nanomedicine for other amyloid-related disorders.

Public health relevance
PUBLIC HEALTH STATEMENT Development of a novel exosome-based nano-scavenger for targeted amyloid-beta removal Alzheimer's disease (AD), the leading cause of dementia among the elderly, is marked by the accumulation of toxic amyloid-beta (Aβ) proteins. Current treatments have struggled to halt or reverse AD progression due to their inability to degrade existing Aβ plaques. Our project seeks to address this challenge with a novel nano- medicine called Exosome-Based Nano-Scavenger (EBNS), which is engineered to precisely target and effectively degrade Aβ proteins, offering a promising avenue for AD treatment.